Data Management and Analysis Core (DMAC)

The Data Management and Analysis Core (DMAC) will be led ISytanley Azen, PhD, and the Associate Core Leaders will be Kiros Berhane, PhD and Chih-Ping Chou, PhD. This team of investigators will provide a broad array of expertise and support across the center activities in the general area of data management and statistical analysis. The Specific Aims of the DMAC are the following: 1) To provide data management and statistical support for Center research activities;2) To provide an interface between Center investigators and statistical resources;3) To train existing Center investigators and personnel, new investigators and trainees in principles of data management, biostatistics, clinical trials, longitudinal analysis, epidemiology and prevention research;4) To stimulate collaboration between statisticians and other investigators by providing a focal point for statisticians to discuss issues with investigators;and 5) To develop innovative methodological approaches arising from the research programs of the Center. All projects and pilot studies will utilize this Core.